State-dependent modulation of learning

PROJECT SUMMARY
Animals can modulate learning in response to differing internal and external environments. Layering context
onto learned information can enhance the diversity and specificity of memories, and can allow efficient access
to situation-specific behaviors. In state-dependent learning (SDL), information learned by an animal while it is
in a particular internal “state” is most effectively recalled when the animal is tested in the same internal state.
Drug intoxication-induced SDL can be observed across diverse animal species, including humans. We will
employ a model of ethanol intoxication-induced SDL that we have developed in the nematode Caenorhabditis
elegans to define the molecular mechanisms that are required for SDL to occur. The simple and highly
conserved nervous system of C. elegans provides an excellent model in which to study the molecular events
that underlie SDL. When worms experience an attractive olfactory cue in the absence of food, they can learn to
associate the odorant with starvation and attenuate their response to it in a process called olfactory learning
(OL). We have shown that OL can become state-dependent; when animals undergo OL while they are
intoxicated, they only express the learned behavior when they are tested in the same intoxicated state. We
have shown that the internal intoxication state is encoded by a secreted peptide signal and its receptor during
OL, but, surprisingly, this signal does not encode intoxication state during recall of OL. Here, we will identify the
mechanisms by which state is encoded during recall of state-dependent OL. We will define the neural circuit in
which SDL occurs and the inputs into it that signal state during both learning and recall. We will distinguish
between two explanations for the lack of expression of state-dependent OL when the animals are tested in a
non-intoxicated state: forgetting (loss of the learned information) or failing to recall (the learned information
remains, but the memory is only accessible when the animals are intoxicated). We will determine if other drugs
besides ethanol can confer state-dependency on OL. Finally, we will probe the generalizability of SDL beyond
OL by asking if learning paradigms that use other neural circuits and signaling systems can become state
dependent. Successful completion of these aims will provide novel molecular insight into how context cues are
added to learned information.

Public health relevance
PROJECT NARRATIVE The processes of learning and memory can be shaped by internal and external contextual cues. State- dependent learning occurs when learning happens while the subject is in a specific internal state (e.g. intoxication) and the memory is only recalled when the subject is in the same internal state. This project aims to develop a molecular understanding of how state is encoded and how it modulates the processes of learning and remembering.